The Unrecognized Role of Phosphate-accumulating Bacteria in Oral Health

The long-term goal of the project is to better understand how diverse oral bacteria modulate
phosphate concentrations near the tooth interface. This likely has a significant influence on the
balance of oral health in children and adults. This project proposes a new and previously
unrecognized mechanism of phosphate modulation in the oral cavity. This project will
investigate how specific bacteria in the oral environment can accumulate external free
orthophosphate to internally synthesize and store long chains of phosphate as polyphosphate
(poly-P). This process has the potential to create undersaturated conditions at the tooth
interface and accelerate subsurface tooth demineralization (tooth decay) under acidic
conditions. Bacteria that accumulate poly-P may also, under specific conditions, release their
internally stored phosphate, into the external environment leading to ion oversaturation, which
may have a protective role. Our group has determined through genomic screening and direct
evidence, that the majority of species associated with acute dental decay have the ability to
accumulate poly-P. This project will investigate how the diverse microbiome in the oral cavity
contains these specific phosphate-accumulating bacteria that are modulating phosphate ions
within the biofilm. In this project, we will: 1) identity, quantify, and localize the oral bacterial
species capable of polyphosphate-accumulation that are found in carious lesions; 2) determine
to what degree these phosphate-accumulating bacteria mediate mineral dissolution and/or re-
precipitation; and 3) determine which conditions mediate polyphosphate accumulation and
extracellular phosphate release in different oral bacteria species. The novelty of this work is
rooted in the remarkable past discoveries of the oral human microbiome. Our project will
explore how a diverse class of bacteria within the oral microbiome may not possess the classic
virulence-related factors, but play a significant and active role in dissolution via the ion
exchange pathway specifically via phosphate accumulation and release. This unrecognized
mechanism is likely a key aspect of maintaining oral hard tissue health and preventing and
managing dental cavities in children and adults.

Public health relevance
Project Narrative/Public Health Relevance This project explores an unrecognized mechanism in the caries process that affects children and adults. We will examine how biofilms modulate ionic phosphate concentrations at the tooth surface. Our work will positively benefit the preventative oral health of pediatric and adult patients and may lower long-term dental healthcare costs by improving testing of therapeutic caries preventive agents.